Cardiovascular Research Empowerment Workforce

Abstract
The goal of this application is to develop a research training program in the US Virgin Islands (USVI) that
inspires a new generation of underrepresented minority (URM) students to pursue research careers targeting
cardiovascular health. We propose an eight-week intensive summer research institute delivered in partnership
between the University of Miami Miller School of Medicine (UMMSM), Virgin Islands Department of Health
(VIDOH), and University of the Virgin Islands (UVI), a historically Black College and University. A HRSA-
designated Health Professional Shortage Area, USVI is a culturally-distinct Black region that disproportionately
suffers from CVD, with 80% of USVI residents reporting at least one major CVD risk factor. VIDOH, the
region's leading healthcare system, faces numerous challenges including an inadequate health system
infrastructure and diminishing healthcare workforce. Over 30% of federally funded VIDOH positions are vacant
and 42% of funded public health positions are unfilled. Lack of data, limited research capacity, and flight of
skilled human capital further exacerbate these challenges. In response, we propose the Cardiovascular
Research Empowerment Workforce (CREW) program aimed at increasing knowledge, skills, and motivation of
URM scholars to pursue research careers. UMMSM is a national leader in URM training with an extensive
research infrastructure and training expertise targeting learners at all academic levels. Aligned with the USVI’s
healthcare context, CREW will leverage UMMSM’s rich, interdisciplinary research environment to prepare a
cohort of emerging URM researchers to address CVD and related disparities in the USVI. The aims of the
program are to: 1) facilitate immersive research experiences for USVI college students addressing CVD
and related disparities; 2) implement an engaging curriculum that supports meaningful research
experiences and nurtures trainee potential to envision a CVD-focused research career; and 3) establish
a support network among trainees and CREW mentors for ongoing mentorship, research collaboration,
and grad school preparation. Adapted from UMMSM’s existing URM pipeline programs, CREW curricula will
draw from UM research centers, including the Clinical and Translational Science Institute, Translational Sleep
Center, Office of Diversity, and Florida Stroke Center. During the eight-week experience, CREW scholars will
receive hands-on exposure to CVD-related research, professional development, and continuous research
training through immersion in a specific USVI-based research project. In the five-year funding period, 50 URM
scholars from USVI will receive mentorship and learn strategies to create culturally-tailored cardiovascular
interventions from evidence-based models in clinical and basic sciences. By doing so, the program will further
develop USVI’s undergraduate research training infrastructure and promote locally designed research
addressing CVD disparities, serving as a catalyst to increase the representation of USVI scientists in the
healthcare workforce.

Public health relevance
Project Narrative To inspire a new generation of underrepresented minority (URM) students to pursue research careers in cardiovascular disease (CVD) and related comorbidities, we propose a five-year, disparities-focused research training program for undergraduate college students from the United States Virgin Islands (USVI). An eight- week intensive summer research institute, the Cardiovascular Research Empowerment Workforce (CREW) aims to advance health equity by supporting the training and career development of the next cadre of underrepresented minoritized researchers. As the USVI is a designated health professional shortage area, the proposed program will strengthen the local healthcare infrastructure by preparing emerging scholars to conduct evidence-based research within the local healthcare context, succeed in graduate school, and pursue a cardiovascular-focused research career in the USVI.